Identifying EEG Markers of Altered Interoceptive Processing in Chronic Pain

PROJECT SUMMARY:
Chronic pain is a complex, medically unexplained disorder that poses enormous burden to both the patient and
the healthcare system. In the face of the opioid epidemic, the need for better scientific understanding of the
neuro- and psycho-biological underpinnings of chronic pain to guide improved treatment approaches is clear.
Non-pharmacological interventions, including contemplative and integrative practices, have shown efficacy in
improving pain and bolster efforts to reduce opioid-ergic medical management. These interventions often target
the processing of internal painful and non-painful sensory signals, referred to as interoception. Neural processing
of interoceptive stimuli overlaps with many of the regions altered in chronic pain, and self-report interoceptive
questionnaires and tasks show diminished interoceptive performance in pain patients. However, the translational
relevance of interoceptive functioning in pain treatment trajectories has been hindered by the lack of clear tasks
and questionnaire measures of interoception.
The overall objective of this proposal is to establish whether neural processing of non-painful interoceptive
stimuli, namely the heartbeat, is altered in chronic low back pain patients at various stages of treatment and
predictive of non-response to invasive peripherally-targeted treatments compared to healthy adults. This NRSA
project will identify how electrophysiological dynamics (EEG/ECG) are related to interoceptive processes and
pain treatment response using two newly developed, validated, and rigorously controlled interoception tasks that
assess neural responses to the heart (Heartbeat-Evoked Potential, HEP). I will systematically test the
hypothesis that chronic pain patients will display diminished modulation of the HEP during attention to
their heartbeat compared to healthy controls (Aim 1) and impaired interoceptive-exteroceptive
integration when an exteroceptive tone previously synchronized with the heartbeat is unexpectedly
omitted (Aim 2). I will also test that these measures at baseline can predict non-response to pain
intervention. Together, these data will establish whether neural markers of non-painful interoceptive processing
could be clinically relevant biomarkers for guiding treatment selection in chronic low back pain, and would have
broad implications for the incorporation of behavioral interventions targeting interoceptive processing. In
preparation for this NRSA, I have sought out mentors who have expertise in interoceptive tasks,
electrophysiology (EEG and ECG) data acquisition, analysis and interpretation, clinical interventional pain
management, and complementary and integrative pain care. This proposal was designed to give me the training
needed for a future profession as a Pain Management physician conducting research on interoceptive dynamics
in chronic pain, and their relation to healing with integrative medicine modalities.

Public health relevance
Project Narrative This project will investigate cardiac interoception as a possible biomarker of chronic pain that is maintained by telencephalic as opposed to peripheral mechanisms, where poorer interoceptive behavioral and neural performance would predict non-response to peripherally targeted treatments. Using EEG measures of the Heartbeat-Evoked Potential during interoceptive tasks, this project will establish the clinical relevance of interoception to chronic pain by comparing healthy adults, chronic low back pain patients pre-back surgery, and those who have not received pain relief from back surgery and have been diagnosed with Failed Back Surgery Syndrome and will receive a spinal cord stimulator for pain management. A cross-sectional design across the continuum of care for complex low back pain will enable identification of cardiac interoceptive processes that can predict non-response to peripheral pain treatment.